Institutional Career Development Core (KL2)

The Mentored Career Development (KL2; Core I) program of the Institute for Integration
of Medicine & Science has 3 primary objectives: 1) to develop clinical and translational scientists who can
effectively participate on interdisciplinary research teams; 2) to expand the workforce of clinical and translational
researchers representing or focusing on our target populations: Hispanics, active-duty military personnel, and
veterans; and 3) to collaborate actively with other CTSA hubs and the national CTSA Consortium. Our cadre of
CTSA-supported Scholars has been supplemented by partnering with the Older Americans Independence
Center and the School of Medicine, broadening the base of talented young investigators benefiting from the
program. During our first 9 years, we have appointed 27 Scholars, representing a very diverse mix of disciplines,
racial/ethnic backgrounds, and gender, with 33% underrepresented minorities (URMs) and 64% women.
Thirteen of our 19 graduates have received and/or been on teams that received NIH funding. All 19 are in full-
time university or industry clinical or translational research and/or leadership positions.
The KL2 program's success is due to the high caliber of our candidate pool, the strong commitment to team
mentorship, robust program leadership, and the exceptional institutional commitment and intellectual
environment. All Scholars can tap into a wealth of resources, including coursework in our Certificate, Masters,
and PhD programs; Office of Research, Education and Mentoring services; the Forming of Research Greatness
& Expertise K Club; the Grant Writing with New Investigators peer mentoring group, and methodologic support
from our Biostatistics, Epidemiology and Research Design (BERD) core.
For the new funding period, we will train 4 KL2 Scholars at any given time, and will continue to include in our
activities those supported through other programs or by the institution. Our planned new initiatives emanate from
multiple sources, including feedback from Scholars and mentors, our collective experience running KL2
programs, and best practices from the CTSA Consortium. Planned enhancements thus include: training in team
science; a variety of externship opportunities; mentor training; a personalized pathways approach to competency
attainment; added representation on our Program Advisory Committee by a community member, a URM faculty
member, and a military medicine researcher; a guaranteed third year of support from the Scholar's home
department, if needed to obtain an individual K or R grant; and even closer ties to the Claude D. Pepper Older
Americans Independence Center and the Research to Advance Community Health (ReACH) Center.